MOLECULAR MECHANISMS OF THE COCHLEAR EFFERENT FUNCTIONS

DESCRIPTION: (Adapted from applicant's abstract): Cochlear functions are subject to modulation by higher auditory centers in the brain via the olivocochlear (OC) efferent system, which is believed to provide protection against noise damage and improve our communication ability in the presence of noise. A development role for the OC efferent has also been suggested by recent works showing that severing the OC efferent bundle in neonatal animals hinders the normal development of the high sensitivity and selectivity of the cochlea. The cellular and molecular mechanisms of the OC efferent function are poorly understood. The long-term goal of our study is to understand the molecular mechanisms of the OC efferent in modulating the activities of afferent fibers and to explore its role in the development of normal cochlear functions. This proposal will focus on one of the two OC efferent systems, the lateral OC (LOC) efferent which forms axodendritic synapses with the radial afferent fibers underneath the inner hair cells. Our overall Hypothesis is that the cholinergic and GABAergic neurotransmission in the LOC